Development of lesion-targeted lncRNA nanotherapeutic for vascular smooth muscle dysfunction

PROJECT SUMMARY
Neointimal hyperplasia (NIH) is a significant issue that arises from vascular damage during interventions,
leading to arterial wall thickening and lumen loss. This condition is primarily caused by the phenotypic transition
of vascular smooth muscle cells (VSMCs). Excessive migration and proliferation of these dysfunctional VSMCs
contribute to NIH, which ultimately causes stenosis and restricts blood flow. Preventing or reversing this
pathological transition in VSMCs could be a promising strategy to mitigate NIH following interventions.
Recent studies have identified a long noncoding RNA called cardiac mesoderm enhancer-associated
noncoding RNA (CARMN), which plays a critical role in VSMC differentiation and maintenance of contractile
functions. Disruptions in CARMN regulation have been linked to VSMC dysfunction and NIH. Decreased
expression of CARMN has been observed in dedifferentiated VSMCs and diseased blood vessels. Furthermore,
studies have shown that genetic ablation of CARMN exacerbates neointima formation, while CARMN
overexpression attenuates NIH in mouse and rat models of vascular injury. These findings strongly suggest that
restoring CARMN regulation in dysfunctional VSMCs could be a viable strategy to mitigate NIH and improve the
outcomes of vascular interventions. Based on these insights, our research project aims to develop a lesion-
targeted nanotherapeutic that utilizes CARMN transcripts as the pharmaceutical agent for the treatment of VSMC
dysfunction and NIH. Building on our prior successful research with platelet membrane-cloaked nanoparticles
(PNP) as an efficient targeted delivery system for injured vasculature, we have integrated in vitro transcribed
(IVT) CARMN RNA into PNP, creating PNP-CARMN. Our preliminary findings demonstrate that PNP significantly
increases the uptake of CARMN by cultured VSMCs and improves targeted delivery of CARMN in the denuded
mouse artery. Importantly, in mice subjected to a wire-injury procedure, PNP-CARMN effectively mitigates arterial
wall thickening compared to those loaded with GFP mRNA. These preliminary results indicate that PNP-CARMN
has the potential to address VSMC dysfunction and prevent NIH.
The research project will test the overall hypothesis that CARMN transcripts delivered by PNP would
selectively accumulate in the vascular injury sites and promote VSMC contractile gene expression and functions,
there mitigating NIH. The proposed studies involve three Specific Aims, including (1) optimize PNP-CARMN for
nuclear delivery and assess its in vitro effects, (2) investigate the pharmacokinetics and toxicity of PNP-CARMN,
and (3) evaluate the pharmacological responses and therapeutic efficacy of PNP-CARMN against VSMC
dysfunction and NIH. Successful completion of these Aims will provide insight into the therapeutic role of CARMN
and contribute to the development of a new avenue for CVD treatments that can benefit millions of Americans.

Public health relevance
PROJECT NARRATIVE Vascular injuries from endovascular procedures can cause smooth muscle cell dysfunction, leading to neointimal hyperplasia and ultimately stenosis. This project seeks to combat this by developing a lesion-targeted RNA nanotherapeutic, which delivers the transcripts of lncRNA CARMN to restore smooth muscle cell functions and reduce neointima formation. The insights gained from this study could pave the way for innovative strategies to treat stenotic vascular diseases and improve the outcome of medical interventions.